A single-cell platform to discover and study regulators of human development

DESCRIPTION (provided by applicant): A single-cell platform to discover and study regulators of human development Human pluripotent stem cells (PSCs), which have the potential to form virtually any cell type in the body, have been the subject of intense research focus due to their potential application to regenerative medicine and the more recent potential for patient specific stem cells via reprogramming, allowing differentiated adult cells to be turned into pluripotent ones. However, in the shadow of this excitement, the potential to exploit pluripotent stem cells for fundamental studies in human developmental biology has been overlooked. This is especially pertinent given the fundamental physiological differences between the human and mouse - the closest relative where such studies are typically carried out. The long-term goal of my future research program is to use PSCs to discover and characterize new regulators (i.e. genes, metabolites, growth factors, non-coding RNA) of the human developmental processes. In order to accomplish this it will be necessary to create a platform (set of methods and analytical tools) to allow the modeling, tracing, and comparison of the paths by which human stem cells differentiate under natural and investigator-controlled situations. To this end, I will use a next-generation single-cell analysis instrumentation (CyTOF mass cytometry), which I have previously used to measure levels of protein expression, regulatory modifications, cell cycle and cell death across most known cell types in human bone marrow in response to drugs, cytokines, and growth factors, to characterize this system. I will first create a single cell templte of pluripotent cells undergoing differentiation using standard differentiation conditions. I will ten create a set of computational tools that will not only take into consideration the dynamic nature of cellular differentiation, but also enable the comparison of differentiating cell-types in differnt investigator controlled conditions. Finally, I will use stable gene knockdown approaches to target genes of interest based on proteins previously identified as differentially expressed in human PSCs versus their differentiated counterparts. Together this pipeline of experimentation will result in the establishment of a new and unique platform (a method for data collection, a method for data analysis and interpretation, and a proof-of-concept of its implementation) for the characterizing putative regulators of cellular differentiation.

Public health relevance
Human pluripotent stem cells (hPSCs) are potentially powerful tools for regenerative medicine because they have the ability to grow indefinitely as well as form virtually any tissue in the body. However they also present an opportunity as an indispensable tool to model and study factors that regulate early human developmental biology. The goal of this project is to develop a set of tools to comprehensively analyze hPSCs under different conditions in order to identify new factors that influence them, and ultimately human development.